Culprit Plaque in Acute Cerebral Infarction: A Histological and MRI Assessment

DESCRIPTION (provided by applicant): Every 40 seconds, one person in the U.S. has a stroke. Stroke is the fourth leading cause of death overall (third leading among women), it accounts for one of every 18 deaths in the U.S., and it is the third leading cause of death in China. Data from the Sino-MONICA-Beijing Project indicate that the incidence of ischemic stroke in 25-74 year old individuals has doubled between 1984 and 2004, from 100.5 to 213.2 per 100,000. Stroke is also the leading cause of serious, long-term disability. Amongst ischemic stroke survivors 65 years of age and older, 50% have some hemiparesis, 30% are unable to walk without assistance, 19% have aphasia, and 26% are institutionalized in a nursing home six months following their ischemic event. In 2008, the direct and indirect cost of stroke in the U.S. was $34.3 billion2 and projected costs in 2050 exceed $2.2 trillion, leading to calls for greater focus on secondary stroke prevention in the U.S. and in China. The goal of this research is to provide imaging techniques that will help clinicians select the most appropriate treatment strategy for the individual patient. We aim to accomplish this goal through development of improved methods for the detection and localization of the atherosclerotic lesion responsible for stroke, referred to as the culprit plaque. Furthermore, we seek to provide insight into novel markers and risk factors for development of the high-risk plaque. Findings from this study will lay the foundation for prospective studies that will assess whether presence of an MRI-detected culprit plaque poses a higher risk for recurrent stroke, and whether specific circulating markers predict progression to a high-risk plaque.

Public health relevance
PUBLIC HEALTH RELEVANCE: Stroke is one of the leading causes of death and long-term disability in China and the United States; extracranial and intracranial cerebrovascular disease is a major contributing factor. The optimal approach to treatment, which includes medical therapy, endarterectomy, or stenting, varies depending on the location of the lesion responsible for the ischemic event, referred to as the culprit plaque. The long-term goal of our research is (1) to provide clinicians with novel diagnostic imaging tools that will aid in the selection of the most appropriate treatment strategy for the individual patient and (2) to utilize these tools to better understand the pathophysiology and risk factors involved in the development of the high-risk atherosclerotic plaque. __SpecificAimsTextDelimiter__ Specific Aims: Stroke is one of the leading causes of death and serious long-term disability in China and the United States.1-4 While these populations share the burden of this potentially preventable disease, there appear to be important differences in the pattern of cerebrovascular disease between China and the U.S. that may affect the approach to optimal treatment. This variation in cerebrovascular disease may be due to differences in environment and/or genetics; these disparities can inform the pathogenesis. We will leverage our expertise in plaque imaging, genetics, and our access to these populations to quantitatively define variation in plaque features, and determine if cyclin-dependent kinase inhibitor (CDKN1B) promoter genotype predicts plaque characteristics and population differences. A disrupted luminal surface (DLS; e.g., fibrous cap rupture or ulceration), intraplaque hemorrhage (IPH), and mural thrombus (MT) are hallmarks of the culprit plaque - the atherosclerotic lesion responsible for ischemic events.5-9 Establishing the location of the culprit plaque is critical in guiding therapy for secondary stroke prevention. Certain culprit carotid plaques may be best treated with carotid endarterectomy (CEA) or stenting.10, 11 Infarcts secondary to intracranial disease may be better managed by intensive medical therapy.12 Therefore, in patients with coexisting extracranial carotid and intracranial disease, identifying the location of the culprit plaque is of particular importance for guiding appropriate therapy. As noted above, there appear to be key differences in cerebrovascular disease between U.S. and Chinese patients. There is up to a five-fold higher prevalence of intracranial plaque amongst Chinese patients compared to Caucasians.13, 14 Intracranial plaques with culprit lesion features are seen three times more frequently in China than in the U.S.9, 15 In a small study comparing extracranial carotid plaque features using magnetic resonance imaging (MRI), symptomatic U.S. patients tended to have more carotid plaques with culprit lesion features than patients from China.16 Much of what is known about cerebrovascular culprit lesions is based on small studies using a variety of methods. A large international study using coordinated technology is needed to better define the pattern of cerebrovascular disease and to examine the risk factors associated with differences observed in the U.S. and China. Our collaborative research team is well positioned to successfully address these issues. For nearly two decades, our laboratory has been at the forefront in the development of high-resolution MRI techniques to identify culprit plaque features in the carotid and intracranial arteries. MRI has been applied in clinical studies by multiple groups.17-40 Tiantan Hospital is a major referral center for acute stroke patients in China, and our collaborators have a large experience with MR plaque imaging.41-46 We have collected over 400 carotid plaques in Seattle, and this repository is available for comparison to specimens in China. Lastly, we have more than a decade-long collaboration with Dr. Gail Jarvik, Head of UW Medical Genetics, investigating the association of genetic risk factors and the high-risk plaque. Analysis of our preliminary carotid MRI data revealed a higher prevalence of thin or ruptured fibrous caps in subjects with a single nucleotide polymorphism in the promoter region of the CDKN1B gene (-838C>A). We propose to study the association between the CDKN1B -838A allele and carotid fibrous cap status by histology and by MRI, and to assess whether differences in genotype frequencies in the U.S. and China predict part of the variation in plaque characteristics. In summary, we will test the central hypothesis that the location of culprit lesions and the risk factors associated with high-risk plaques differ in China and the U.S. Accurate localization of the culprit plaque will have important implications for treatment. The specific aims are: 1. Implement a standardized MRI protocol and assess the reproducibility for detection of plaques with disrupted luminal surface, IPH, or MT in the extracranial carotid and intracranial arteries. 2. Determine whether the prevalence of DLS or IPH/MT is lower in plaques removed from symptomatic patients undergoing carotid endarterectomy in China (n=150), compared to CEA patients in the U.S. (n=150 existing samples). As an exploratory sub-aim, we will test the hypothesis that patients with intracranial culprit plaques on MRI will be more likely to experience recurrent symptoms (TIA or stroke) in the 12 months following CEA, compared to patients without intracranial culprit lesions. 3. In patients with a history of recent TIA or stroke who have an ischemic, anterior-circulation infarct on brain imaging, determine if intracranial culprit plaques are more common in Chinese patients (n=200) and extracranial carotid culprit plaques are more common in U.S. patients (n=100), as identified by MRI. 4. Determine if the CDKN1B, -838A allele is associated with presence of 4a) thin or ruptured fibrous cap on histology (n=150; Aim 2 CEA cohort); and 4b) thin or ruptured cap on carotid MRI (n=450; Aims 2 and 3 MRI cohorts). We will also assess the difference in frequency of genotypes between Chinese and U.S. subjects to determine if it correlates with differences in plaque characteristics between these populations.